Clinical Oncology Research Program (CORP)

PROJECT SUMMARY/ABSTRACT
The overall goal of the Clinical Oncology Research Program (CORP) is to support the intent of the Paul Calabresi
Career Development Award for Clinical Oncology (K12). CORP fosters interdisciplinary training in clinical and
translational oncology therapeutic research for early career faculty physicians (Assistant Professor) in one of a
number of oncology disciplines, including medical, surgical, dermatologic, pediatric, radiation and pathology. By
designing a K12 program that brings together these broad disciplines, the Paul Calabresi Scholars themselves
form a multidisciplinary group whose collaborations and interactions augment the overall training efforts under
the K12 program. The two-year training program with an option for a third year for Scholars who would benefit
from additional training will support 4 Scholars a year. Firm core requirements include completion of required
and elective course work for a Certificate in Clinical Translational Oncology Research at Case Western Reserve
University. A basic research effort is a required part of the training program and is linked to the clinical research
efforts that include writing and activating a therapeutic clinical protocol and submission of a career development
award application. These efforts will result in highly qualified Paul Calabresi scholars capable of independent
research in clinical oncology and therapeutics with a team science orientation based in hypothesis testing of
important translational questions in the field. CORP brings together strong Internal and External Advisory
Committee members committed and experienced in the area of clinical translational therapeutics research in
oncology. CORP and the Case Comprehensive Cancer Center provides scholars with an outstanding
environment to pursue career development. Past trainees have emerged as academic physicians developing
independent clinical research programs often with external funding and with active investigator-initiated clinical
trial efforts.

Public health relevance
PROJECT NARRATIVE The Clinical Oncology Research Program (CORP) is a mentored career development program at the Case Comprehensive Cancer Center. CORP supports physician investigators to gain skills in cancer research and clinical therapeutics that emphasizes innovative treatments and use of genomics to select proper and individualized treatments for cancer patients, increasing the likelihood that such treatment will be effective.